Evaluating, Preparing, and Responding to Care Disruptions and Health Outcomes Among Patients with Breast Cancer Following Severe Storms

Project Summary/Abstract
Severe storms, whether hurricanes or other storms with significant wind/precipitation, affect millions of
Americans each year, disrupt the delivery of healthcare, and increase the risk for health complications. While
severe storms may impact the care and outcomes of any cancer, addressing its impact on patients with breast
cancer, a highly prevalent cancer with a good overall survival when treated with high-quality care, is of high
public health significance. The primary research objective of this proposal is to recognize treatment disruption
and adverse health outcomes experienced by patients with breast cancer and to identify and prioritize
strategies to respond to health needs. In this study, we employ a mixed methods framework to accomplish the
following aims: (Aim 1) To assess the impact of severe storms on breast care, acute care services, and
mortality among patients with breast cancer, identify the most vulnerable populations, and evaluate potential
mediators for the three outcomes; (Aim 2) To describe disruptions in breast cancer care, community concerns,
perceived care barriers, and strategies to mitigate care disruptions and respond to health needs following
storms using depth interviews of key stakeholders; (Aim 3) To identify and prioritize targeted interventions to
mitigate disruptions in breast cancer care and respond to post-storm health needs through Delphi methods and
community engagement. I am supported by a mentorship team with expertise in oncology, climatology, health
services research, geospatial analysis, mixed methods, and disaster preparedness. I will link storm data,
including wind speed, flooding, and power outage, with breast databases to quantify the impact of severe
storms on the care and outcomes, identify mediators on the causal pathway and create geospatial maps to
identify impacted communities and health systems. Then I will conduct depth interviews with diverse
stakeholders in cancer care and disaster preparedness. Intervention mapping framework will be used to
identify strategies, which are then are assessed and prioritized by stakeholders during Delphi and a community
engagement working group. Through mentored training, education, and carrying-out this research proposal, I
will accomplish my training goals related to applying new quantitative methods, acquiring skills in qualitative
analysis and mixed methods, developing knowledge in implementation science and community engagement to
prepare strategies for intervention studies, and developing the skills and network for career independence as a
physician scientist. This proposal will provide the foundation for my independent physician-scientist career in
health services research focusing on environmental health threats and cancer care and outcomes. By
identifying vulnerable subgroups and potential mediators in Aims 1 and describing and prioritizing strategies in
Aims 2 and 3, this proposal will support the implementation and evaluation of the most promising strategies in
a future R01.

Public health relevance
Public Health Relevance Each year hundreds of thousands of the nearly 4 million breast cancer survivors in the US experience severe storms. Despite a growing recognition that severe storms disrupt cancer treatment and increase the risk for acute and long-term health complications, there is a knowledge gap regarding which populations of patients with breast cancer are most vulnerable to severe storms and strategies that may be implemented to mitigate care disruption and respond to health needs. This study will examine the impact of severe storms on cancer care and health outcomes of patients with breast cancer and engage with diverse stakeholders to identify and prioritize strategies to be implemented to improve health services and outcomes among patients with breast cancer following severe storms.